The Michigan PBB Cohort: A unique, highly exposed community followed for 45 years and three generations

Research Plan Summary/Abstract
The Michigan PBB Cohort is the longest running, multi-generational cohort study of a widespread
environmental contamination event in the United States. More than 40 years ago, millions of Michiganders ate
farm products contaminated with polybrominated biphenyls (PBB), a chemical flame retardant. This cohort of
approximately 7,500 individuals includes those who ate the contaminated food, chemical plant workers, their
children, and their grandchildren. Extensive health, exposure, and biological samples have been collected from
these individuals for four decades. While systematic updates of this cohort ceased in 2003 due to paucity of
infrastructure funds, the Emory team pursued hypothesis-driven research with NIH funding. Research based
on the Michigan PBB Cohort has demonstrated relationships between exposure to PBB and many health
outcomes, including thyroid conditions, breast cancer risk, lower Apgar scores in children, reproductive health
in daughters, and genitourinary abnormalities in sons. Current NIH-funded research includes innovative
approaches involving genomics, epigenomics, exposomics and metabolomics across multiple generations as
well as a randomized clinical trial of a nutritional aid hypothesized to speed elimination of PBB. The PBB
research team has been exceedingly productive, contributing over 150 scientific communications. The PBB
cohort has served as a source of data and biospecimens for eight NIH R01 grants, two EPA STAR grants, an
NIH R03, and an NIH R21, reflecting the important scientific questions that can be addressed with this cohort.
Importantly, for the last 6 years, the affected Michigan community has become a partner in the PBB research
efforts, dedicating their time and resources to support the continuation of this work that is so meaningful to their
family's and community's health. To assure this valuable cohort is accessible and useful for future studies and
data sharing, with this R24 support we plan to update the vital status of the entire cohort and to develop a
state-of-the-art data management and analytic platform. This platform will enable linkage of over 40 years of
follow-up data and thousands of biospecimens. Using state of the art web-based communication, we will
develop web portals to enable broad sharing of the cohort resources with three important stakeholder groups:
the scientific community, cohort members (to access their own data), and local public health agencies. This
infrastructure grant will support research addressing the long-term impact of exposure to brominated flame
retardants, which continues to be found in the blood of the vast majority of Americans - making the intensive
study of this unique cohort relevant to all Americans.

Public health relevance
Project Narrative The Michigan PBB Cohort is a state-wide, multi-generational cohort of approximately 7500 individuals who ate food contaminated with PBB (polybrominated biphenyls), chemical plant workers, their children, and their grandchildren. The national importance of the Michigan PBB Cohort in understanding the health risks from brominated flame retardants remains high as these chemicals are routinely detected in the US population, are associated with serious health outcomes, and new “replacement” flame retardants continue to be used in consumer products. The overarching goal of this proposal is to develop an infrastructure for the cohort's vast data and biological specimens that will enhance the ability of researchers to determine health effects of the exposure and to serve the Michigan community by providing information that will help them and their physicians take appropriate steps to protect their health.